American Society of Gene & Cell Therapy (ASGCT) 15th Annual Meeting

DESCRIPTION (provided by applicant): The American Society of Gene & Cell Therapy (ASGCT) was founded in 1996. ASGCT's mission is to advance knowledge, awareness, and education leading to the discovery and clinical application of genetic and cellular therapies to alleviate human disease. Our Annual Meeting represents the major educational initiative of the Society and has been CME-accredited for all of our prior 14 meetings. This R13 proposal requests support for travel grants for trainees. Over 1/4 of our members are scientists-in-training working to develop clinically applicable gene- based technologies. Trainee participation in the Annual Meeting is fostered by an outstanding educational program, trainee travel awards, and recognition of outstanding scientific accomplishments through peer-reviewed trainee Excellence in Research Awards. Over the past decade, the ASGCT has offered 470 travel grants and 63 Research Awards, with almost 190 travel grants made possible by R13 grant awards from the NIH during that same time. Educational opportunities for travel awardees include exceptional plenary speakers, state-of-the-art scientific symposia, and educational sessions that review current thinking on a variety of topics. In addition to leading scientists and clinicians, the program includes ethicists and representatives from the FDA, OBA, and NIH so young scientists may gain insight into the compliance and ethical issues related to human gene therapy and cell therapy. Trainees are active presenters in oral abstract and poster presentations, and the top trainee abstracts are recognized at the Presidential Symposium. The size of the ASGCT meeting (approximately 1,700 participants) is ideally suited to expose young scientists to leaders in the field yet provide opportunities for trainees to present their work at the premier meeting in the field of gene and cell therapy. NIH support for the ASGCT Annual Meeting will allow continued educational and professional advancement of trainees in the field of cell and gene therapy and the opportunity to network with leaders in the field. PUBLIC HEALTH RELEVANCE: The American Society of Gene & Cell Therapy (ASGCT) is seeking funding for 20 travel awards for post-doctoral fellows and students who submit scientific abstracts for its 15th Annual Meeting in May 2012. Travel awards are given to students and post-doctoral fellows who apply for the awards and who receive the highest scores during the peer review process.

Public health relevance
The American Society of Gene & Cell Therapy (ASGCT) is seeking funding for 20 travel awards for post-doctoral fellows and students who submit scientific abstracts for its 15th Annual Meeting in May 2012. Travel awards are given to students and post-doctoral fellows who apply for the awards and who receive the highest scores during the peer review process.